Request for administrative supplement to purchase a confocal microscope for project GM139971

Our current project (R01 GM139971) is focused on elucidating the mechanisms
by which non-centrosomal microtubule-organizing centers (ncMTOCs) function.
This is important because many, if not most, non-dividing cells in the organism
rely on ncMTOCs rather than the centrosome, the better understood animal
MTOC. Considered a new frontier in cytoskeleton research, ncMTOCs are
diverse in their structures, subcellular locations, and mechanisms of microtubule
assembly. My lab has discovered three distinct ncMTOCs in the past few years,
and in this project we focus on discerning the mechanisms by which a
perinuclear MTOC in Drosophila adipocytes is assembled and by which it
controls microtubule assembly. To achieve the aims of this grant and future
projects, confocal microscopy is needed to execute and evaluate experiments
and is the most critical core piece of equipment for my research program. The
general and ongoing need for intensive confocal microscopy use is reflected in all
of our publications in the past 13 years, where we have had ready access to a
Nikon A1 confocal microscope housed adjacent to our lab. This instrument is
used daily by members of my lab and is now aged, slow and in disrepair. A
supplement to fund a new confocal microscope is necessary to assure progress
with this project and allow us to retire the current instrument.

Public health relevance
Microtubules constitute a major cytoskeletal network required for many diverse and critical cellular functions such as structural support, molecular and vesicle trafficking, etc, that is coordinated from specific organizing centers that vary according to cell type and which serve the unique functions of those cell types. The goals of this proposal supplement are to support the purchase of a confocal microscope, a key piece of equipment that will allow us to accomplish the aims to determine the mechanisms by which non-centrosomal microtubule-organizing centers (MTOCs) function, and to define new paradigms for microtubule assembly that have emerged from this project and are expected to broadly impact physiology, disease, and development.